A Bruker timsTOF HT mass spectrometer and nanoflow LC system to upgrade the proteomics facility at Rutgers-New Brunswick and Robert Wood Johnson Medical School

Project Abstract
This is an application requesting funds to purchase a Bruker timsTOF HT mass spectrometer and NanoElute 2
liquid chromatography system that will be used for proteomics research. The instrument will be integrated into
the Robert Wood Johnson Medical School/Rutgers-New Brunswick Biological Mass Spectrometry Facility in
Piscataway New Jersey. We current operate two mass spectrometers, a Thermo Eclipse tribrid, which is used
for the majority of our projects and an almost 10-year old Thermo QExactive HF. There are two justifications
for our request. First, we need additional capacity. The Eclipse is used at maximal capacity thus we require
additional an instrument to meet the demands of our NIH-funded investigators. In addition, we have no substitute
for the Eclipse when the instrument in inoperable - the QExactive, which is close to the end of its functional
lifespan, cannot replace the Eclipse for most projects. Second, we need additional capabilities. The proteomics
field is increasingly turning towards label-free, data-independent acquisition (DIA) methods for proteome-wide
quantitative mass spectrometry. Our Eclipse is an excellent instrument in many respects but our comparison
studies clearly indicate that the Eclipse is inferior to the Bruker timsTOF in terms of proteome coverage, number
of peptides assigned and accuracy of quantitation. This instrument will greatly enhance the ability of NIH-funded
scientists on the Piscataway and New Brunswick campuses of Rutgers University to conduct cutting-edge
biomedical research and it will also provide access to cutting-edge technology for the many new junior Faculty
recruits at Rutgers. Availability of this technology will allow our User group to better address a wide range of
specific diseases including asthma and respiratory disease, neurological disease, bacterial and viral infection,
disruption of endocrine function, skin disorders, sleep disorders, diabetes, digestive disease, inflammation and
cancer, as well as other fundamental issues of biomedical importance. The requested instrument will represent
a significant asset to our research community and will accelerate the pace of basic and applied biomedical
research of NIH-funded investigators on the New Brunswick and Piscataway campuses of Rutgers, the State
University of New Jersey.

Public health relevance
Project Narrative In this proposal, the Robert Wood Johnson Medical School/Rutgers Biological Mass Spectrometry Facility is requesting funding for a mass spectrometer. This instrument will greatly enhance the ability of scientists on the Piscataway and New Brunswick campuses of Rutgers University to conduct cutting-edge biomedical research and will provide access to cutting-edge technology for many new junior Faculty recruits at Rutgers. Research in areas of medical importance including asthma and respiratory disease, neurological disorders, bacterial and viral infection, endocrine dysfunction, sleep disorders, diabetes, digestive disease, inflammation and cancer, will be facilitated by the requested instrument.